Molecular Programs Governing Enterococcal Translocation

Molecular Programs Governing Enterococcal Translocation
Enterococcus faecalis is a commensal microbe residing in the gastrointestinal tract of healthy individuals.
However, in hosts with dysbiosis or altered gut homeostasis, these bacteria can overgrow, breach intestinal
barriers, and cause life-threatening systemic infections. This process, known as translocation, remains a largely
unexplored phenomenon. Our team uncovered that E. faecalis produces a polysaccharide-rich extracellular
matrix (ECM) that enables its movement across intestinal epithelial cell barriers. However, the mechanisms by
which host cells perceive and respond to stress signals generated by these translocating enterococci remain
elusive. Additionally, whether E. faecalis exploits specific molecular pathways in epithelial cells to facilitate its
translocation remains unknown. Our project aims at addressing these fundamental gaps in knowledge. We
postulate that E. faecalis induces endoplasmic reticulum (ER) stress in epithelial cells and that activation of the
unfolded protein response (UPR) through this process promotes enterococcal egress from the intestine. Our
study is innovative and significant because it has the potential to uncover key molecular mechanisms
mediating E. faecalis transition from commensal to pathogen. Aim 1 will define how E. faecalis disrupts ER
proteostasis in epithelial cells. Aim 2 will establish that E. faecalis-induced ER stress responses compromise
intestinal barrier function. Aim 3 will test the hypothesis that disabling ER stress sensors in vivo thwarts
enterococcal translocation in hosts experiencing antibiotic-induced dysbiosis. The proposed research will be
accomplished by integrating our multidisciplinary expertise in E. faecalis pathogenesis, ER stress biology, and
intestinal physiology. We have developed advanced models of translocation, crucial transgenic mice, sensitive
ER stress reporter systems, and a unique understanding of the interplay between enterococci and the host UPR.
The proposed studies could pave the way for new treatments that more effectively prevent or control systemic
infections caused by gut-resident enterococci. Our project should also provide a strong rationale to define if other
commensal bacteria exploit the UPR to cross intestinal barriers, hence expanding our mechanistic understanding
of host-microbe interactions in the gut.

Public health relevance
PROJECT NARRATIVE Enterococci are typically harmless bacteria that reside in the human gut. However, these microorganisms can overgrow and breach the intestinal barrier, leading to life-threatening infections in distant organs. This project will uncover a key mechanism used by enterococci to egress from the intestine, which could be controlled using novel pharmacological approaches.